CORE--ANIMAL CORE

The Specific Aims of the Animal Core are: 1. To serve as a regional referral center for dogs with spontaneous tumors that will be treated on projects in this program. 2. To provide the necessary diagnostic and staging services to assess whether animal patients are suitable for treatment in the program. 3. To provide personnel resources for administration of treatments used in dogs with spontaneous tumors treated in this program. 4. To provide personnel resources for follow-up of dogs with spontaneous tumors treated in this program. 5. To provide quality assurance for standardization of treatments for projects in this program in which dogs with spontaneous tumors are treated. 6. To provide data accrual and archiving support regarding information collected from dogs treated on projects in this program.